Identification of Novel Protein Kinases Dependent on Phosphocreatine Rather than ATP

Abstract
Post-translational modifications of proteins are a major mechanism for the modulation of protein activity.
Among these, the most common is protein phosphorylation by a set of enzymes called protein kinases.
Protein kinases (PKs) are involved in almost every pathway of biological significance in eukaryotes.
Metabolic regulation requires protein kinase function in every system, including insulin and glucagon
action, glycogenolysis, adipogenesis and adaptive thermogenesis. Excessive AKT protein kinase activity
downstream of insulin action is also suspected of being a key link between obesity and cancer. The
mammalian kinome includes some 560 known enzymes, about 0.2% of the entire coding genome. As far
as it is known, every one of these enzymes utilizes ATP as a high-energy phosphate donor, transferring
the γ-phosphate of ATP onto (mainly) serine, threonine or tyrosine residues. Nature has developed
another high-energy phosphate containing molecule that is often more abundant than ATP:
phosphocreatine (CrP). Because ATP is an inhibitor of ATP synthase, cells can't store ATP. Instead, the
γ-phosphate of ATP can be transferred to creatine (Cr), regenerating ADP and allowing the electron
transport chain to continue functioning in the “forward” direction. Our recent work has demonstrated a
non-canonical function of Cr and CrP in thermogenic adipose cells, which run a futile cycle of creatine
phosphorylation and de-phosphorylation. This futile cycle expends energy without doing work and hence,
results in the generation of heat. This work demonstrating a broader function of creatine than “just”
energy storage caused us to ask an unusual question: are there protein kinases that preferentially use
CrP? In fact, we have demonstrated here, using high-resolution protein Mass Spectrometry, that brown
fat cell extracts can utilize CrP to phosphorylate certain peptide sites (at both S/T and Y residues) that
are not modified when ATP is used as a substrate. Our key goals moving forward are to (1) demonstrate
that these phosphorylation events are direct phosphate transfer reaction from CrP to target proteins (2)
to demonstrate that these phosphorylations are dependent on CrP in vivo, using murine models of Cr
and CrP-deficient animals (3) purify and characterize the CrP-dependent PKs. These may be new
members of the kinome or known PKs that alter peptide target specificity when they use CrP as a
substrate (4) perform biochemical and biophysical studies to characterize the enzymatic reactions and
identify the CrP binding sites on the PKs. (5) investigate the physiological importance of the CrP PKs, by
mutating specific target sites in protein targets and ablating the CrP-dependent PKs themselves. This
project will open up a potentially important new area in biochemistry and physiology, and represents a
“high-risk, high-reward type of project for which the Catalyst Award is intended.

Public health relevance
Project Narrative The known protein kinases transfer phosphate from ATP to target proteins to modify their activity. We now show that certain enzymes can phosphorylate new protein sites using creatine phosphate as the phosphate donor. We will identify and characterize these new enzymes biochemically and determine their physiological importance through the use of genetically modified mice. !